Stanford Center for Clinical & Translational Education and Research (Spectrum)

Contact PD/PI: Cullen, Mark R.
0. Overall: Abstract
The mission of Spectrum, Stanford's CTSA-supported research Hub, is to transform clinical and
translational research and education at Stanford and across the Hub network to make it more effective at
discovering and implementing data-driven strategies to serve the health needs of individuals and the population
and to disseminate that knowledge to trainees and the public. Spectrum's programs are designed to extend from
the earliest stages of the translational pipeline to the “final mile” of implementation science at the patient and
population levels. During the next five years, Spectrum will leverage the gains and achievements made over the
past decade, our institutional strengths and resources, and advancements in the focus of the national network
of CTSA Hubs to nurture an innovative and collaborative workforce that can transfer health discoveries from the
University to patients and the community.
Spectrum's purpose is to support essential resources and educational opportunities to ensure the current
and ongoing success of this mission. To that end, our first overarching aim is to educate the next generation
of investigators who make up the clinical and translational research (CTR) “workforce” with the skills to carry out
innovative clinical, translational, and implementation research to meet the opportunities and challenges of health-
care delivery and wellness maintenance in the 21st Century. Our second overarching aim is to maximize
community engagement and team science to ensure that the products of our research benefit all segments of
the population including special populations, people with rare diseases, minorities and women, vulnerable
populations such as children and the elderly, and the medically underserved. Our third overarching aim is to
create an institutional home that provides investigative teams with ready access to the methods, processes,
services, and assessment tools necessary to efficiently translate those discoveries that will substantially alter
health outcomes in order to directly improve the health and well-being of individuals and the population. Finally,
our fourth overarching aim is to develop informatics-based CTR methods, processes, services, and
assessment tools necessary to efficiently translate discoveries into improved health outcomes while reducing
costs, promoting compliance, and ensuring data availability. Such enhancements will broadly facilitate our CTR
mission. With Spectrum's strong track record of accomplishments, supportive institutional environment, well-
developed infrastructure and leadership, and our ever-expanding network of collaborators, including health-care
systems, other Hubs, and community partners, we are well-positioned to execute on our vision for the next five
years.
Page 173
Project Summary/Abstract
Contact PD/PI: Cullen, Mark R.
0. Overall: Narrative
The mission of Spectrum, Stanford University's CTSA-supported Hub, is to transform clinical and
translational research and education (CTRE) to ultimately serve the present and future health needs of
individuals and the population. Spectrum will support essential resources and educational opportunities in four
broad areas, i.e., innovative translational discoveries, team science approaches, innovative training methods for
the CTR workforce, and good stewardship of all resources, to ensure the current and ongoing success of this
mission. To achieve its mission, Spectrum will work closely with its local, regional, and national partners,
including and especially with the other Hubs in the CTSA Consortium, while using a series of well validated
metrics to continuously assess and improve performance.
Page 174

Public health relevance
The mission of Spectrum, Stanford University's CTSA-supported Hub, is to transform clinical and translational research and education (CTRE) to ultimately serve the present and future health needs of individuals and the population. Spectrum will support essential resources and educational opportunities in four broad areas, i.e., innovative translational discoveries, team science approaches, innovative training methods for the CTR workforce, and good stewardship of all resources, to ensure the current and ongoing success of this mission. To achieve its mission, Spectrum will work closely with its local, regional, and national partners, including and especially with the other Hubs in the CTSA Consortium, while using a series of well validated metrics to continuously assess and improve performance.